BIOLOGICAL MAGNETIC FIELD EFFECTS VIA RADICAL PAIR MECHANISM

We are trying possible linkages of reported magnetic field effects in biology (such as sensory capabilities of certain animals and possible health effects of fields in medical instrumentation, near power lines, etc.) to one or more radical pair reactions via quantum mechanical calculations and experimental data. Work in the EPR Center has focused on calculation techniques for treating oscillating fields and simulation of magnetic field effects in coenzyme B12 systems.